The impact of menthol regulation for cigarettes and e-cigarettes on tobacco use patterns for current menthol smokers

Abstract
The Food and Drug Administration (FDA) is working to finalize a ban on menthol cigarettes. Finalizing a ban,
navigating litigation from the tobacco industry, and implementing the ban will be a lengthy process. Some
organizations have advocated that non-tobacco flavorings, including menthol, should also be banned from other
tobacco products like e-cigarettes. Despite the wealth of cross-sectional and uncontrolled studies of menthol,
we have very little prospective, experimental data investigating the impact of a menthol ban on tobacco use for
menthol smokers in the United States, and even less evidence on how a menthol ban for e-liquids might interact
with a cigarette menthol ban. If menthol is banned from both cigarettes and e-cigarettes, menthol smokers who
otherwise would have tried to switch to e-cigarettes may continue to smoke cigarettes or quit using tobacco
altogether. Thus, the impact of a cigarette menthol ban on changes in tobacco use may depend on whether
menthol is banned in e-cigarettes. The proposed trial is a 2x2 between-subjects randomized controlled trial
investigating the impact of a menthol bans for cigarettes and e-cigarettes on tobacco use patterns including
cigarette smoking, e-cigarette use, use of medicinal nicotine, and cessation-related behaviors. Current menthol
smokers (N=240) will complete a 1-week baseline period before being assigned to either menthol or non-menthol
cigarettes and either menthol or tobacco-flavored e-liquid for 7 weeks. To model a ban, smokers will be instructed
to only use their assigned products, and adherence will be assessed using self-report and a urinary biomarker
for menthol. Changes in tobacco use patterns (cigarettes smoked per day, e-cigarette use, ability to abstain from
smoking) will be assessed through electronic daily diaries (Aim 1). Secondary outcomes include cigarette and
e-cigarette subjective effects, and cigarette and e-cigarette dependence (Aim 2). To assess the ability to abstain
from smoking, participants will complete a 1-week practice quit attempt in Week 7, and we will assess the time
to first smoking lapse. Self-reported tobacco use is corroborated by biomarkers for smoke and nicotine exposure
(expired carbon monoxide, urinary cotinine). Finally, it is critical to understand how menthol regulation will impact
the entire population of US menthol smokers, as well as the effect on vulnerable groups where menthol smoking
is concentrated. Thus, we will use advanced statistical techniques to assess whether any baseline demographic
or smoking variables moderate the treatment effect. Then, we will calibrate the treatment effects to the US
population of menthol smokers, and model the impact on smoking and vaping attributable deaths and life years
lost (Aim 3). The strong investigative team, coupled with our success using the proposed methodology, enhances
the probability of success in achieving our aims. This project will be the largest, most rigorous clinical trial to
directly test the impact of menthol regulation for cigarettes and e-cigarettes on current menthol smokers.

Public health relevance
Project Narrative The United States Food and Drug Administration is planning to implement a ban on menthol cigarettes, and the future of e-liquid flavoring, including menthol, remains unclear. The proposed project will be among the first randomized controlled trials to assess the impact of a cigarette menthol ban and an e-cigarette menthol ban on cigarette use, e-cigarette use, and the ability to abstain from smoking among current menthol smokers.